Assembly of the eukaryotic large ribosomal subunit

Project Summary
Ribosomes are molecular machines composed of ribosomal RNAs and up to 80 ribosomal proteins.
These large assemblies catalyze protein synthesis in all cells. The long-term goal of this project is to
understand how eukaryotic ribosomes are assembled with the help of more than 200 non-ribosomal
factors as a series of molecular snapshots of assembly intermediates. Combining genetic, biochemical
and mass spectrometry approaches with cryo-EM is an essential step to engineer, trap, isolate and
determine atomic-resolution molecular snapshots of transient assembly intermediates of ribosomal
subunits.
Eukaryotic ribosome assembly can be subdivided into four stages, co-transcriptional assembly events
and initial maturation of small and large ribosomal subunit precursors in the nucleolus, nuclear
maturation of pre-40S and pre-60S particles, nuclear export, and cytoplasmic maturation. While late
events in eukaryotic ribosome assembly are relatively well characterized, the early co-transcriptional
assembly of ribosomal subunits in the nucleolus is still poorly understood. Intermediates at these very
early stages are extremely short-lived and transient and structures of key protein complexes that
catalyze these early events have so far remained elusive.
My laboratory has developed new genetic and biochemical approaches that now enable us to efficiently
tag, trap and isolate early nucleolar assembly intermediates of the large ribosomal subunit. The
synergistic use of these approaches has allowed us to overcome previously intractable biochemical
hurdles, thereby enabling the detailed study of essential early assembly intermediates of the large
ribosomal subunit and the stepwise formation of the polypeptide exit tunnel, one of its functional
centers. Insights from these studies will shed light onto both the mechanisms that are employed during
eukaryotic ribosome assembly to form functional centers as well as how defects in eukaryotic ribosome
assembly can result in human blood disorders, which are collectively termed ribosomopathies.

Public health relevance
Project Narrative The proposed research is relevant to public health as it addresses a link between defects in eukaryotic ribosome assembly and the resulting human blood disorders. Ribosomes are the molecular machines responsible for protein synthesis in all human cells. As genetic diseases associated with ribosomal protein coding genes are linked to abnormalities in the synthesis of ribosomes, this research program will be essential to understand the molecular underpinnings of these diseases.